KOMP2 Annual meeting: The BCM Knockout Mouse Production and Phenotyping Project (BCM KOMP2)

The goal of the International Mouse Phenotyping Consortium (IMPC) is to develop a resource of null allele
lines for every protein-coding gene in the mouse genome and, through standardized, broad-based
phenotyping, catalog the biological function of each targeted gene. The NIH-funded Knockout Mouse
Phenotyping Project (KOMP2) has supported two previous phases of null allele production and phenotyping,
contributing to more than half of the null allele lines made and characterized by the IMPC. This application
describes our plan for Baylor College of Medicine (BCM) to continue as a KOMP2 site during a third phase of
funding. We propose to produce, cryopreserve, and phenotype null allele mouse lines for 600 protein coding
genes. We have developed a bioinformatics approach to identify and prioritize genes with known or putative
human disease associations but little-to-no in vivo functional annotation for null allele mouse line production.
We will generate and validate null alleles using established CRISPR genome editing approaches and quality
control procedures, cryopreserve all null allele lines using accepted techniques, and deliver germplasm to the
MMRRC repositories for communitywide distribution. These null allele lines represent a gold standard resource
for the scientific community and an important foundation for future research and translational studies. We will
utilize our established pipelines to perform broad-based, standardized adult phenotyping on all mutant lines
and assess homozygous lethal and subviable lines in an embryonic phenotyping pipeline. The phenotyping
data we generate will provide fundamental new insights into mammalian biology as well as the genetic bases
of human disease. All allele and phenotype data will be submitted in real time to the Data Coordination Center,
ensuring the rapid dissemination of all BCM data to the wider biomedical scientific community. We will continue
our production and phenotyping technology development programs, developing our own new approaches and
adopting new methodologies from the community as they arise. The BCM KOMP2 team has the established
expertise, experience, and resources to meet the proposed phase 3 goals in an efficient and cost-effective
manner.

Public health relevance
NARRATIVE We propose to continue our efforts as part of a consortium for large-scale production and phenotyping of knockout mice. The generation of mutant alleles and broad-based, systematic phenotyping will reveal gene contribution to mammalian biology and define new functions and pathways underlying the mechanisms of disease. All mouse lines and their phenotyping will be publicly released as they become available.